In-cell analysis and elaboration of RNA-targeting fragment ligands

Project Summary
The function and regulation of both coding and non-coding RNAs depend on their structures. A subset of RNAs
contain pockets capable of binding ligands, and targeting RNA with small molecules can potentially modulate
gene expression and cell state. To date, identifying and progressing these ligands within cells has posed a
formidable challenge. I have developed a technology for transcript-specific detection of ligand binding in cells
that is scalable for high throughput screens. This method simplifies the complex RNA ligand measurement into
a manageable and efficient PCR-based strategy, which I used to discover a first-site fragment ligand that binds
the 5’-UTR of MYC, a conventionally difficult-to-ligand target. In Aim 1, I propose to use my in-cell screening
platform to discover molecules that exhibit enhanced binding to MYC mRNA when bound by the first-site ligand.
Potential hits will be chemically linked to create ligands with substantially higher affinity than either ligand alone.
My current first-site binder reduces c-MYC protein levels without affecting mRNA levels, suggesting translational
regulation. In Aim 2, I will use functional studies to address a critical gap in our understanding of how small-
molecule ligands can target RNA, to produce meaningful biological effects, focusing on how RNA structure
affects ribosome recruitment to the mRNA. This project is designed to provide a comprehensive understanding
of ligand-RNA interactions in cells, informing the development of RNA-targeted tool compounds and, ultimately,
therapeutics. The overarching vision of this research and training program integrates RNA screening
technologies, bioinformatics and cheminformatics, mechanistic studies, and mentoring opportunities. Through
this program, I will gain a strong foundation for a career as an independent researcher and leader in RNA
chemical biology and therapeutics.

Public health relevance
Project Narrative Most of the human genome encodes RNA, highlighting its crucial role in biological processes and its viability as a target for therapeutic interventions. Consequently, the development of platforms aimed at targeting RNA with small molecules is poised to transform drug discovery and the development of scientific tools, moving beyond the conventional focus on proteins. This training and research proposal aims to equip the applicant with hands-on experience in tackling these significant challenges by developing methods for screening RNA ligands within cellular environments.